Evaluation of Smoke-Free Housing Policy Impacts on Tobacco Smoke Exposure and Health Outcomes

ABSTRACT. By December, 2020, COVID-19 associated hospitalization rates among Hispanic/Latino and
African-American/Black persons in the United States were twice as large as non-Hispanic White persons. New
York City (NYC) became the epicenter of COVID-19 early in the epidemic and disturbing patterns of COVID-
related disparities rapidly emerged. In October 2020, we launched a Rapid Acceleration of Diagnostics for
Underserved Populations (RADx-UP) targeting NYC public housing residents, leveraging longstanding
partnerships with the NYC Housing Authority (NYCHA), the NYC Health Department, the NYC public hospital
system responsible for contact tracing (NYC Health +Hospitals) and a robust set of community partners to
execute a data-informed, community-engaged research project to develop and test strategies to increase
adoption of COVID-19 testing among NYC public housing residents. NYCHA is the largest public housing
authority in North America, with more than 400,000 official residents living in 15% of the nation’s public housing
units. Median family income is $20,000, and approximately 90% of NYCHA residents are either black or
Hispanic. Through the RADx-Phase I project, we developed a strong community engagement structure to
guide our work, designed and launched weekly surveillance of COVID -19 infections and testing rates at all
374 developments across NYC, facilitated COVID-19 testing sites on public housing grounds, and launched an
intervention trial using NYCHA resident community health workers. Now, to address the facts that transmission
is predominantly occurring among younger age groups, we are introducing point-of-contact saliva testing and
on-the-spot vaccine scheduling, as well as testing methods to extend reach. Our new aims are to: 1) Expand
and sustain our community engagement infrastructure; 2) Apply near-real time surveillance to direct mobile
testing and popup vaccination clinics to public housing developments citywide; 3) Discover facilitators and
barriers to testing and vaccination in two new priority groups (teens/young adults and homebound older
adults); and 4) Test supervised point-of-care saliva testing and vaccine scheduling modalities. By building on
our early successes, strong partnerships, robust municipal data sources, and a rapidly expanding array of
testing initiatives, this implementation study offers the opportunity to tailor strategies to address real barriers in
extending testing and vaccination services to a large, high-need population. Findings will be used to develop
guidance for implementing testing strategies in multi-unit and public housing settings nationally.

Public health relevance
PROJECT NARRATIVE This study builds on a successful RADx-UP Phase I study to engage New York City public housing residents to evaluate delivery of acceptable COVID-19 testing options, particularly in the new context of vaccine availability. This extension project tests approaches to expand reach using point-of-contact saliva testing, with added strategies to reach teens/young adults, the primary group contributing to COVID-19 transmission. Findings will be used to develop guidance for public housing settings nationally.